Impact of germline variants on racial and ethnic differences in somatic mutation frequency

Summary
Tumor sequencing data have revealed significant differences in mutation frequencies between racial and
ethnic groups. Some of these differences can be attributed to environmental exposure, such as smoking
frequency, but disparities persist even after adjustment for known factors. Well-described examples include
TP53 mutations that are seen at elevated rates in breast cancers in African-Americans compared to Asian and
non-Hispanic White women and KRAS mutations that are observed in higher rates in colorectal cancers from
African-Americans relative to other racial groups. As cancer aggressiveness and survival can depend on what
pathways are perturbed in a tumor, the frequency at which a cancer driver mutation occurs in a population
should influence some of the observed racial disparities in outcomes. Emerging data from our lab and others
suggest that germline genetic variants impact somatic events in tumors. We identified associations between
AURKA variants and TP53 in head and neck squamous cell carcinomas from The Cancer Genome Atlas. We
found that individuals with at least one AURKA allele previously associated with cancer risk were more likely to
have gain-of-function TP53 mutations relative to individuals homozygous for the non-risk associated allele.
These and other studies suggest an association between germline Genetic variants and somatic Mutations
(GxM) in tumor development. This study will search for novel Genetic variants associated with TP53, PIK3CA,
and KRAS Mutations in order to explain racial differences in tumor biology. In this study, we will test the
innovative hypothesis that germline genetic variants that differ in frequency between racial groups drive the
observed racial differences in frequency of somatic mutations. Our goals are to understand the association
between somatic mutations, germline genetic variants and tumorigenesis in racial disparities, and to determine
the biological impact of GxM associations on cancer phenotypes using in vitro models. Using existing genotype
and mutation data, these goals will be accomplished in two aims: 1. To identify and characterize GxM
associations for TP53 and PIK3CA mutations in breast cancer in order to understand how germline variants
drive racial differences in somatic mutation frequency. Variants found in GxM association studies from 3700
individuals with breast cancer will be evaluated in 4000 additional breast cancer cases from multiple racial and
ethnic groups. Top GxM interactions will be assessed functionally using CRISPR/Cas9 to create knock-in and
knock-out mutations and alleles. 2. To identify and characterize GxM associations for KRAS mutations in
colorectal cancer (CRC) using a similar approach in Aim 1. These studies will apply a novel concept to
discover new biological drivers for racial disparities in cancer outcomes, as measured by mutation frequencies.
Results from this study have the potential to inform mechanistic studies which, in turn, will lead to new
therapeutic strategies for cancers showing racial differences in mutation frequency and outcome.

Public health relevance
Public Health Relevance The frequency of mutations in genes driving tumor growth for cancers such as breast and colon differs between ethnic and racial groups and is known to affect tumor aggressiveness and prognosis. This study aims to identify genetic variants that vary in frequency between ethnic and racial groups that impact which mutations are more likely to occur in a tumor. Identification of these variants and their functional roles in the cell may uncover new therapeutic strategies for prevention and treatment.